Erie County Health Department Risk Factor Study and Continued Conformance with the FDA Voluntary National Retail Food Regulatory Program Standards

Project Summary/Abstract The Erie County Health Department (ECHD) Eire County, Ohio is seeking a $70,000 award from the U.S. FDA’s Voluntary National Retail Food Regulatory Program Standards Grants Program to advance conformance with Standards 2,3,7 8 and 9. Goals include: ? Standard 2: Trained Regulatory Staff- re-standardize a food inspection staff member as a food Safety Inspection Officer (FSIO) to then re-standardize other ECHD food safety personnel and train antipated new hires in accordance with stated protocols ? Standard 3: Inspection Program Based on HACCP Principles- develop required written policies including on-site corrective actions appropriate to the type of violations, long-term control of risk factors, follow-up activities to assure compliance, code variance requests related to risk factors and verification/validation of Hazard Analysis Critical control Points (HACCP) ? Standard 7: Industry and Community Relations- strengthen an Active Managerial Control (AMC) Program with an initial 20 local facilities, offering training and resources to food mangers. ? Standard 8: Program Support and Resources- provide staff with appropriate food inspection tools and equipment used for routine inspections, risk factor evaluations, and food safety trainings ? Standard 9: Program Assessment- conduct an initial phase of a required risk factor study with a focus on schools, grocery stores, hospitals, and healthcare facilities. Specifically, for standard 2, ECHD will seek renewed partnership with the Fairfax county Health Department, Virginia, a previous mentor, to bring their FSIO to ECHD to re-standardize an ECHD lead food inspector. Currently, in Ohio, there is no avenue for local health departments to complete this requirement through a state-based program. ECHD believes participation in these activities are the steps needed to reduce food violations most commonly associated with food borne illness at licensed operations within the jurisdiction. The risk factor study will provide solid baseline data that will be trended over time in order to develop targeted strategies that address the five CDC risk factors known to contribute to food borne illness. The study will identify the needed interventions proven to promote use of specific behaviors that improve and protect public health.

Public health relevance
Project Narrative: The Erie County Health Department (ECHD) seeks to obtain $70,000 in project funding to conduct ongoing food inspection activities that conform to the U.S. FDA’s Voluntary National Retail food Regulatory Program Standards. ECHD, at the local level, is eager to continue progress toward alignment with national best practices that provide a continuous quality improvement process intended to reinforce proper food sanitation practices while focused on reducing common risk factors that contribute to food borne illness. ECHD will: (conduct the first phase of its first risk factor study (Standard 9 Program Assessment) with a focus on the four (4) industry categories of schools, grocery stores, hospitals and health care facilities; 2) retain lead food inspector with expertise as a re- standardized Food Safety Inspection Officer (FSIO) able to reinforce current staff and train new staff regarding proper food inspection practices (Standard 2 Trained Regulatory Staff); 3) strengthen and expand an Active Managerial Control (AMC) Program (Standard 7 Industry and Community Relations) that builds positive relationships with food managers; 4) develop and adopt best-practice policies and plans (Standard 3 Inspection Program Based on HACCP Principles); and 5) purchase tablets and inspection tools that streamline data collection in the field, aid in the assessment and analysis process for continuous quality improvement, and demonstrate proper use of risk reduction during food safety training (Standard 8 Support and Resources)